Model-directed Design of Vaginal Stents to Prevent Post-radiation Stenosis

MODEL-DIRECTED DESIGN OF VAGINAL STENTS TO PREVENT POST-RADIATION STENOSIS
Debilitating vaginal stenosis is an under-recognized, poorly understood sequela that occurs in up to 75%
of patients who undergo pelvic radiation treatments. Patients with vaginal stenosis suffer from pain, inability to
pass menstrual contents, difficulty with pelvic exams, inability to have intercourse, and may require corrective
surgery. There is a critical need for a patient-forward vaginal stent that can apply constant pressure to
maintain vaginal caliber post-radiation treatment. Our proposed design for a self-fitting vaginal stent utilizes a
shape-memory polymer (SMP) foam that can assume a secondary, compressed shape for ease of deployment.
Upon insertion, the change in temperature and hydration initiates foam expansion to shape fit to the individual
patient and restore the lumen of the stent to allow egress of vaginal secretions. Our exciting prior work on the
development of aSMP stent by this team demonstrated deployment with self-fitting shape recoveryand retention
in both benchtop and pilot rabbit studies. In the proposed studies, we will add an antifouling coating to prevent
bacterial attachment and a new geometry for ease of removal. Computational models that capture the complex
geometry, material behavior, and boundary conditions will be developed to provide an in silico testing framework
to accelerate design of gynecological devices. Upon completion, we will have developed aself-fittingvaginal stent
that addresses current egress failures, developed new computational vaginal models and benchtop testing for
gynecological device development, and elucidated key mechanisms in preventing/reversing post-radiation
stenosis. The synergistic team undertaking the proposed studies has the requisite experience in clinical practice
(Hakim), polymer engineering (Cosgriff-Hernandez), shape-memory polymer chemistry (Grunlan), and
computational modeling (Rausch) to complete these studies. Although our immediate goal is to address the
urgent clinical need of post-radiation patients, a self-fitting vaginal stent would have direct extension as a
therapeutic modality for post-surgical vaginal stenosis.

Public health relevance
Debilitating vaginal stenosis is an under-recognized, poorly understood sequela that occurs in up to 75% of patients who undergo pelvic radiation treatments. There is a critical need for a patient-forward vaginal stent that can apply constant pressure to maintain vaginal caliber post-radiation treatment. The proposed studies will develop a self-fitting vaginal stent that addresses current egress failures, create new computational vaginal models and benchtop testing for gynecological device development, and elucidate key mechanisms in preventing/reversing post-radiation stenosis.